QUANTIFICATION OF DRUGS OF ABUSE AND RELATED COMPOUNDS IN BIOLOGICAL SPECIMENS

Since 1974, the National Institute on Drug Abuse has been providing analytical support to research investigators in the drug abuse area for whom this analytical facility and/or methodology is not available otherwise. This contract is about to continuing this analytical service for NIDA supported researchers and also to serve as a reference laboratory by which new methodologies currently under development can be assessed and validated.